Investigating Symbolic Computation in the Brain: Neural Mechanisms of Compositionality

PROJECT SUMMARY/ABSTRACT
Animals exhibit a remarkable array of creative, adaptive, and flexible behaviors. Birds and primates repurpose
new materials to build nests and tools; rats efficiently construct navigational shortcuts, and humans generalize
knowledge of one language to efficiently speak another. This ability to dynamically create novel behavior in one
or a few trials often depends on compositional planning, or the ability to generate new combinations of a finite
number of simple elements in a goal-directed manner. Despite its central importance for understanding
cognition and its disorders, the neural mechanisms of compositionality remain unknown as there is a dearth of
experimental frameworks for studying compositional planning. To address this critical need for new
approaches, this proposal will elucidate neural mechanisms in a novel drawing task that I have developed in
the Freiwald lab, in which macaques draw copies of never-before-seen visual figures. Subjects’ behavior
exhibits a key signature of compositionality in the ability to construct novel combinations of previously learned
elements to draw new images. I will investigate neural and computational mechanisms for compositional action
planning by integrating this behavioral task two other innovations: (1) large-scale recordings in 12 frontal
cortical areas, each implicated in cognition but never recorded simultaneously, which will allow me to discover
how their distinct functions combine to support cognition (Aim 1), and (2) an integrative analysis framework
building and comparing neural network (Aim 2) and symbolic (Aim 3) computational models of compositional
planning with behavioral and neural data. I will test the main hypothesis that compositionality depends on
neural dynamics implementing symbolic cognitive algorithms in hierarchically organized frontal cortical areas.
These studies are expected to discover the first mechanisms, in neural substrates and dynamics, of
compositional action planning. Further, because of these studies’ intersectional approach - testing neural
network (Aim 2) and symbolic (Aim 3) modeling frameworks on the same data - they may unify these two
influential approaches to cognition, which would be a foundational advance for the neuroscience of
intelligence. Correspondingly, this study will contribute to understanding cognitive disorders, including frontal
planning disorders, and to building brain-machine interfaces that decode cognitive plans from cortical activity.
This award will also provide me with crucial training to prepare me for transitioning to independence. I will train
in computational modeling - building, empirically testing, and interpreting these models - which will support my
use of models to generate and test novel neural circuit and computational hypotheses. I will gain important
career development skills in lab management and leadership, scientific communication, and grant writing,
which will support my long term goal of establishing an independent research program on the neural substrates
of intelligence and creative behavior.

Public health relevance
PROJECT NARRATIVE The goal of the proposed research is to explain the underlying mechanisms for a fundamental feature of intelligent behavior, compositionality, or the brain’s remarkable ability to solve new problems by actively creating new cognitive strategies based on combining simpler previously learned strategies in new ways. This research is relevant for understanding what goes wrong in cognitive disorders of planning and decision-making.